Admin Core - The State Alzheimer's Research Support Center (StARS)

Revised Project Summary/Abstract-Administrative and Dissemination Core
Establishment of an experienced, well-integrated, and collaborative Administrative and Dissemination Core is critical to the realization of the State Alzheimer’s Research Support Center’s (StARS’) objectives. The Administrative and Dissemination Core features internationally recognized leaders in the field with demonstrated experience working with stakeholders across the dementia care continuum and in the context of different types of research projects. Building on this Core leadership and expertise, we will apply a team-science approach for overall management and operations to foster wide dissemination and use of Center-developed tools, infrastructure, data, and findings by the broader research and stakeholder communities. Our three specific aims are to: 1) organize, govern, and monitor all StARS activities; 2) provide logistical, funding, and coordination support of all StARS activities; 3) establish a robust outreach and dissemination strategy. We will also initiate linkages to other NIA-funded and other national initiatives to raise awareness of Center activities. Through these efforts, the Administrative and Dissemination Core will support the remaining Cores when completing their respective Aims and ultimately advance the science of integrated/coordinated AD/ADRD care delivery within and across states.